Capacity for histopathologic evaluation of animal tissues in support of FDA Vet-LIRN activities

PROJECT SUMMARY/ABSTRACT This project involves the purchase of a Leica HistoCore BIOCUT manual rotary microtome and a Leica HI1210 water bath for paraffin sections. Our laboratory currently has two sets of comparable histology equipment that allow two histotechnicians to cut paraffin-embedded tissue sections simultaneously; however, these workstations are currently operating at maximum capacity and are unable to accommodate our growing histology caseload, let alone the need for high-volume surge capacity in the event of a disease outbreak or large case investigation. This histology equipment purchase would allow us to establish a third workstation for an additional histotechnician to increase our case throughput and minimize turnaround time for important and time-sensitive pathology case investigations. Our laboratory currently serves as a Vet-LIRN network laboratory to diagnose, characterize, and report emerging and endemic veterinary diseases, including zoonoses. This histology equipment purchase would further strengthen our laboratory’s capacity to investigate animal disease outbreaks to promote both human and animal health.

Public health relevance
PROJECT NARRATIVE This project involves the purchase of a Leica HistoCore BIOCUT manual rotary microtome and a Leica HI1210 water bath for paraffin sections. This histology equipment purchase would allow us to establish a third workstation for an additional histotechnician to increase our case throughput and minimize turnaround time for pathology investigations. This histology equipment purchase would further strengthen our laboratory’s capacity as a Vet-LIRN network laboratory to investigate animal disease outbreaks to promote both human and animal health.